In vivo targeted delivery of nucleic acids to hematopoietic stem cells for treating primary immunodeficiencies

Summary
In this Phase I SBIR, Optimeos will develop an off-the-shelf nanoparticle platform for in vivo stem cell
gene therapy, which we will initially apply to treat ADA-SCID, a severe immune deficiency. We will deliver a DNA
payload in nanoparticles targeting hematopoietic stem and progenitor cells (HSPCs) for gene replacement. We
envision that this non-viral, redosable in vivo HSPC gene therapy will enable the expression of encapsulated
DNA in target cells while improving safety by avoiding viral integration and potential off-target effects. This
therapy has the potential to overcome several challenges posed by ex vivo gene and cell therapies: it could
lower treatment costs, expand treatment availability beyond major academic centers, and reduce patient burden
by obviating the need for chemotherapeutic pre-conditioning. With over 6 million people worldwide affected by
more than 485 distinct inborn errors of immunity, our in vivo HSPC gene therapy platform has the potential to be
transformative for many underserved patients. As an initial indication, ADA-SCID is a disease with established
animal models and clinical pathways to reduce development risks.
Our Coated Inverse NanoCarriers (CINCs) encapsulate nucleic acids in a polymer-lipid hybrid structure
that minimizes inflammation and enhances targeted delivery by providing stable attachment of the targeting
ligand, offering a clear advantage over traditional lipid nanoparticles (LNPs). The targeting capabilities of CINCs
will enable us to reach HSPCs in bone marrow using a selective antibody as a targeting ligand while minimizing
non-specific liver clearance. Across the two aims of this proposal, we will select our lead CINC formulations and
demonstrate durable gene expression in HSPCs with episomally maintained DNA cargos in vitro and in vivo.
Aim 1: Optimize CINC and targeting ligand formulations to achieve potent and specific delivery
to HSPCs in vitro and in vivo. We will select the targeted CINC formulations that exhibit both high transfection
efficiency and specificity in HSPCs, in vitro and in vivo. We expect that lead targeted CINCs will reduce liver
uptake and enhance HSPC transfection compared to control CINCs.
Aim 2: Determine durability and safety of gene replacement in vivo. Utilizing our lead targeted
CINCs, we will deliver an episomally maintained DNA plasmid co-expressing GFP and human ADA genes to
HSPCs, in vitro and in vivo, to assess durability and safety of gene replacement. We expect durable expression
of plasmid DNA in HSPCs and daughter lineages. We expect to observe no concerning safety signals as a result
of the immune-silent design of CINCs and the reduce liver clearance achieved through the course of these aims.
In Phase II, we plan to demonstrate the efficacy of our targeted CINCs in a mouse model of adenosine
deaminase-severe combined immunodeficiency (ADA-SCID).

Public health relevance
To address the limitations of current ex vivo gene and cell therapies, Optimeos Life Sciences proposes, in this Phase I SBIR, the development of targeted nanoparticles for in vivo hematopoietic stem cell gene therapy. This non-viral, redosable therapy aims to provide an off-the-shelf, safe, and transformative treatment for primary immunodeficiencies.